Nuclear and non-nuclear functions of NKX3.1 in suppression of prostate cancer

Project Summary/Abstract
Our studies will investigate mechanisms associated with aging-related prostate cancer progression
through our investigations of the prostate-specific homeobox gene NKX3.1. Work by us and others has shown
that NKX3.1 is essential for normal prostate differentiation, whereas its loss promotes prostate cancer during
aging. NKX3.1 serves as a gatekeeper to protect the prostate epithelium from cancer-promoting insults including
oxidative stress and inflammation. Conversely, NKX3.1 loss abrogates such protection, thereby accelerating
cancer progression. Our recent studies and new Preliminary data show that the traditional functions of NKX3.1
as a nuclear transcription factor are augmented by non-nuclear functions that are also required for suppression
of prostate cancer. Thus, in normal contexts, NKX3.1 is localized to the nucleus where it regulates nuclear target
genes. However, in conditions of oxidative stress, NKX3.1 also becomes localized to mitochondria, where it
regulates mitochondrial genes essential for oxidative phosphorylation (OXPHOS). Our Preliminary data further
show that the consequences of NKX3.1 loss are compounded as cells acquire mitochondrial mutations, leading
to aging-associated acceleration of prostate cancer. In particular, our analyses of mouse models having loss of
function of Nkx3.1 combined with a defective PolgA gene that renders mutated mitochondrial DNA (Nkx3.1;
PolgA mutant mice) reveals aging-related acceleration of prostate cancer with evident mitochondrial dysfunction,
reduced OXPHOS activity, and hallmarks of aging, including cellular senescence and telomere attrition.
Thus, our studies will examine the hypothesis that suppression of prostate cancer by NKX3.1 requires
its nuclear and non-nuclear functions, and that NKX3.1 loss synergizes with mitochondrial dysfunction to promote
prostate cancer during aging. Aim 1 will investigate the nuclear and non-nuclear functions of NKX3.1 in prostate
cancer by leveraging a toolkit of NKX3.1 variants that do or do not bind to DNA, and that selectively localize to
or are excluded from the nucleus or mitochondria to investigate the functions of nuclear and mitochondrial
NKX3.1 target genes. Aim 2 will study the synergy of NKX3.1 loss and mitochondrial dysfunction for prostate
cancer in Nkx3.1; PolgA mutant mice. We will evaluate the functions of selected mitochondrial mutations by base
editing mitochondrial DNA in human prostate cancer cells. Aim 3 will investigate mechanistic determinants of
aging-related prostate cancer progression by identifying master regulators (MRs) of NKX3.1 loss and
mitochondrial dysfunction. Leveraging our biobank of human patient-derived organoid models, we will establish
organoid models having perturbation of selected MRs together with NKX3.1 loss and mitochondrial mutations to
investigate their functions. Altogether, these studies will provide a unique opportunity to investigate
communication between the nucleus and mitochondria, and the role of NKX3.1 in these processes, as well as
mechanistic insights regarding the roles of NKX3.1 loss and mitochondrial dysfunction for aging-related prostate
cancer, and novel mouse and human patient-derived models to study these mechanisms.

Public health relevance
Project Narrative While it is widely appreciated that aging is a key risk factor for many cancers, including prostate cancer, elucidating the underlying mechanisms has proven to be challenging. Our studies reveal context-dependent functions of the prostate-specific homeobox gene NKX3.1 in the nucleus and in mitochondria, which are crucial for the suppression of prostate cancer during aging. Our proposed studies will provide novel mechanistic insights into the roles for NKX3.1 and mitochondrial dysfunction in prostate cancer progression, as well as new genetically-engineered mouse models and human patient-derived organoid models for studying these mechanisms and how they influence aging-related prostate cancer.